The Hawaii NCORP

The overall goal of the Hawaiʻi National Cancer Institute Community Oncology Research Program (NCORP) is to provide access and facilitate enrollment of Hawaii’s unique population to NCI sponsored trials. Thus we will work to accrue a representative population of our catchment area. Our NCORP is the primary provider of NCI clinical trials and cancer care delivery research (CCDR) in the State of Hawaiʻi. The Hawaiʻi NCORP supports an integrated network of affiliates and sub-affiliates with an extensive menu of cancer studies, research infrastructure and data management. Our NCORP has successfully extended CCDR studies from the originally designated sites to other hospital affiliate sites with plans to further extend them to physician office sites. We solicit community input from patient advocates in our community to review the suitability of trials as well as to address their healthcare needs. Non-medical oncology community investigators and staff have leadership responsibility in imaging, prevention and CCDR studies. Our NCORP leaders have extensive experience in cancer clinical trials, health care delivery and issues affecting our unique population. They have served on multiple NCI committees. Participation in NCI’s personalized medicine, cancer control, prevention, treatment and CCDR research will further reduce cancer health care gaps and the cancer burden for the people of Hawaiʻi and beyond.

Public health relevance
The Hawaiʻi NCORP aims to: 1) conduct cancer clinical trials and cancer care delivery research, 2) continue contributing to NCORP research bases and NCI priorities, and 3) enhance participation of Hawai‘i’s population in NCI sponsored trials in order to reduce the burden of cancer for the people of Hawai‘i and our catchment area.